The role of matrifibrocytes in a fibrotic-like response during myxomatous heart valve disease progression

Project Summary
Normal heart valve structure and composition are established by valve remodeling, starting at late
embryonic stages, and continuing postnatally. Valve remodeling results in a stratified extracellular matrix (ECM),
decreased cell density and reduction in cell proliferation. Congenital valve malformations include abnormalities
in valve remodeling such as ECM disruption and disorganization. Congenital heart valve abnormalities due to
ECM gene mutations and defects, often lead to myxomatous valve disease (MVD). Progressive MVD is
characterized by collagen fiber fragmentation, replacement of mucopolysaccharides and proteoglycans, leaflet
thickening, and insufficiency, but the mechanisms mediating progressive valve degeneration remain unknown
and there are no therapies to prevent or reverse MVD. Recently, our group reported that, in an Fbn1C1041G/+
Marfan syndrome (MFS) mouse model, the ECM mechanics and morphological alterations of the mitral valve
occur before functional abnormalities are detectable. Surprisingly, by 6-12 months, collagen fiber remodeling is
increased with abnormal fiber organization suggesting a compensatory fibrotic response. We also observed
induction of matrifibrocyte gene expression associated with collagen-rich connective tissue such as in myocardial
scarring after infarction. In preliminary studies we also observed increased expression of pFAK, a nonconical
focal adhesion kinase (FAK), in MVD at the time of increased collagen production and matrifibrocyte gene
induction, suggestive of a mechanically regulated myofibroblast response. The role of matrifibrocytes and FAK
activation in heart valve disease progression and compensation is unknown. Therefore, we hypothesize that
stress activation and collagen overproduction in MFS mitral valves induce matrifibrocytes causing an
intrinsic reparative response via activated FAK.
We propose three aims to elucidate the role and function of matrifibrocytes in ECM remodeling,
maturation and disease. 1: Determine the contributions of fibrotic ECM in MVD progression in mitral valves, 2:
Determine if valvular interstitial cell (VICs) activation and matrifibrocyte differentiation occur in response to
collagen production and tissue stiffness in mitral valves and 3: To determine if the fibrotic response in the mitral
valve during homeostasis and MVD progression is mediated through FAK activation. The K99 portion of this
proposal will be carried out in the lab of Dr. Katherine E. Yutzey, an expert in heart valve disease, and co-mentor
Dr. Jeffery D. Molkentin, an expert in fibrotic remodeling of the heart. Under their guidance, I will carry out my in
vitro (Aims 1-3A) experiments during the K99 phase and start my in vivo (Aims 1-3B) murine model experiments
during the K99 phase and continue during the R00 phase. Overall, the comprehensive Aims proposed will
provide me with the opportunity to develop an independent research program that will be instrumental in my
success as a scientist. Moreover, the data generated will have important implications for cardiovascular science,
specifically in development of new therapeutic targets for heart valve disease.

Public health relevance
Project Narrative Normal valve remodeling results in a stratified extracellular matrix (ECM), but congenital heart valve abnormalities due to ECM gene mutations and defects, often lead to myxomatous valve disease (MVD). Progressive MVD is characterized by collagen fiber fragmentation, replacement of mucopolysaccharides and proteoglycans, leaflet thickening, and insufficiency, with new insights suggesting that collagen I, stiffness and focal adhesion kinase (FAK) activation may be drivers of matrifibrocytes leading to fibrosis in MVD progression but the mechanisms mediating progressive valve degeneration remain unknown and there are no therapies to prevent or reverse MVD. This proposal seeks to elucidate matrifibrocytes role and function in normal ECM remodeling, maturation and disease progression using in vitro hydrogel platforms and in vivo mouse models, which will help improve therapeutic strategies aimed at preventing or reversing MVD.